A Novel Cognitive Remediation Intervention Targeting Poor Decision-Making and Depression in Veterans at High Risk for Suicide: A Safe,Telehealth Approach During the COVID-19 Pandemic

PROJECT SUMMARY
Despite large-scale, nationwide efforts to better address suicidal behavior (defined as thoughts and
behavior) in high-risk Veterans with major depressive disorder (MDD), the development of interventions that
target some of the key risk factors associated with suicide in Veterans with MDD remains limited. That is, while
much intervention research continues to investigate treatments like cognitive behavioral therapy (CBT) that
target behavioral patterns, emotion processing problems, and cognitive styles associated with suicide risk in
MDD, deficits in the neurocognitive substrates that underlie these CBT targets remain under-addressed.
Cognitive remediation (CR) and rehabilitation have long been a primary treatment for patients with other
psychiatric illnesses, like schizophrenia, for improving cognitive functioning and facilitating transfer of cognitive
skills to every-day functioning. However, scant work has examined CR that addresses the neurocognitive
deficits underlying suicidal behavior in individuals with MDD. Empirical work has identified key executive
functioning (EF) deficits that may be specific to MDD patients with suicidal behavior, and meta-analytic work
indicates that CR has moderate effect sizes on cognitive functioning, depression, and daily functioning in MDD.
Thus, the field is in dire need of work that examines CR as a recovery-oriented treatment approach for MDD
patients at risk for suicide.
The proposed study aims to collect pilot data to test the feasibility and acceptability of adjunctive
neuroplasticity-based CR on key treatment targets delivered via telehealth during this time of COVID-19 in a
sample of 36 Veterans with MDD and a history of suicide attempt(s). Specifically, it will test the effects of an
adjunctive evidence-based cognitive remediation (CR) therapy (adjunctive to treatment as usual) augmented
with manualized “Bridging” sessions on transfer and practice of cognitive control and decision-making/problem-
solving strategies for real-world situations and problems, including those that trigger suicidal thoughts. We
propose to administer the Neuropsychological Educational Approach to Cognitive Remediation (NEAR, termed
CR plus “Bridging” session, CR+Bridging) to a total of 36 Veterans with MDD and a history of suicide
attempt(s). The intervention will be delivered in 20 90-minute sessions (2x/week for 10 weeks). Pre-treatment
assessments of neurocognitive, clinical, social, and real-world functioning will be conducted, including
measures that examine the impact of COVID-19 and its accompanying “social-distancing” restrictions. Post-
treatment assessments of the same targets will be conducted to determine clinical response to and feasibility
of this therapeutic intervention immediately following conclusion of the intervention (Week 10) and at a follow-
up assessment (Week 20). This application is novel in that it constitutes the first implementation of this
intervention in Veterans with MDD and suicidal behavior. Consistent with RR&D’s SPiRE mechanism, this
study is high risk, but it has high potential impact and promise to help improve quality of life for Veterans at
high risk for suicide.

Public health relevance
Despite large-scale, nationwide efforts to better address suicidal behavior in Veterans at high risk, the development of interventions that target some of the key risk factors associated with suicide remains limited. This study aims to collect pilot data to test feasibility/acceptability of a novel adjunctive evidence-based cognitive remediation (CR) therapy with manualized “Bridging” sessions for transfer and practice of problem- solving strategies for real-world stressors, including those that trigger suicidal thoughts. This 10-week (20 session) Neuropsychological Educational Approach to Cognitive Remediation CR+Bridging telehealth intervention will be administered virtually via HIPPA-compliant services to 36 Veterans with major depressive disorder and a history of suicide attempt(s). Pre-, post-treatment, and follow-up assessments of neurocognitive, clinical, social, and real-world functioning also will be conducted. This study has potential for high public health impact and promise to help improve quality of life for Veterans at high risk for suicide.